Molecular and Neural Mechanisms of Temperature Preference Rhythm in Drosophila

SUMMARY: Circadian rhythm is important for human physiology and health. Human body temperature
increases during wakefulness and decreases during sleep. This body temperature rhythm (BTR) is a robust
output of the circadian clock and is fundamental for maintaining homeostasis and its related processes, such
as sleep and metabolism. The long-term goal of our research is to understand the molecular and neural
mechanisms by which BTR is regulated and how BTR is related to sleep regulation.
To understand the mechanisms of BTR, we use Drosophila. This model has provided many strong
contributions to studying the circadian clock, including the discovery of conserved mammalian circadian clock
genes and mechanisms. We demonstrated that Drosophila exhibits a circadian rhythm of temperature
preference, referred to as temperature preference rhythms (TPR). While mammals regulate BTR by generating
or losing internal heat, small ectotherms, including Drosophila, regulate BTR via selecting an environmental
temperature. As flies are small ectotherms, their body temperature is close to that of the surrounding
environment. Thus, Drosophila TPR produces BTR in a similar pattern as mammals. Furthermore, our study
provides the first evidence that fly DH31R and its mammalian homolog, Calcitonin receptor, CALCR, regulate
BTR. Thus, understanding fly TPR will provide fundamental insights into the molecular and neural mechanisms
that control BTR in mammals.
Using fly TPR, in this study, we will address an outstanding knowledge gap regarding how
temperature fluctuations are determined and how the preferred temperature is set at a specific time of day. We
will elucidate the molecular and neural mechanisms underlying TPR. We will examine the distinct functions of
each pacemaker by manipulating their activities and neuropeptide-receptor signals which could control
temperature fluctuation or temperature setpoint. We will clarify the mechanistic difference between TPR and
locomotor activity, focusing on a noncanonical pathway that we anticipate to be a specific regulator of TPR.
This study will unveil the unique neural circuits controlling fly TPR. Further, we will take advantage of fly TPR
and determine the mechanistic link between temperature change and sleep; their relationship has been well
known, but the underpinning molecular mechanism has been a big mystery. This study will facilitate an
understanding the regulatory mechanisms underlying BTR and its relationship to sleep.
We have shown that parallel mechanistic functions between mammalian BTR and fly TPR; thus, the
basic foundation of BTR is aligned with fly TPR. The outcome of this R35 proposal will facilitate to reveal BTR
mechanisms in mammals and lend actionable insights into the treatment of circadian clock diseases, sleep
problems, and the health of night-shift workers.

Public health relevance
PROJECT NARRATIVE The circadian clock controls most aspects of human life and health. Based on our studies during the past 13 years, we believe that temperature preference rhythm in Drosophila is an innovative model for understanding fundamental regulatory mechanisms of body temperature rhythms in mammals. Our studies will expand the current understanding of mammalian body temperature rhythm, sleep disorders, and general sleep-associated issues, such as jet lag or the sleep disturbances common to night-shift workers.